Understanding the Role of the Built Environment for Mobility in Older Adults

DESCRIPTION (provided by applicant): Mobility, defined as an individual's ability to move about effectively in his or her surroundings, is fundamental to independence and quality of life. Difficulty with mobility (mobility disability) is highly prevalent in older adult populations, with negative consequences for independence and social isolation. Recent models of disability draw attention to the role of environmental factors that can interact with an individual's underlying impairments or capacities to impede or enhance a person's ability to be independent in mobility. For example, living on a street without continuous, barrier-free sidewalks may hinder mobility for a person living with pain or leg weakness due to arthritis. Using secondary analyses with data from the recently launched National Health and Aging Trends Study (NHATS), this proposal aims to further our understanding of the dynamic nature of the disablement process. Funded by the NIA, NHATS is a nationally representative study designed to support the investigation of disability trends and dynamics in later life. NHATS uses innovative measures of disability and function, captured both objectively (through physical performance measures) and subjectively (through survey questions), to tease apart the various elements along the disablement process. In addition, interviewer observations of each respondent's residential location provide objective data on the barriers and facilitators in the surrounding built environment. Drawing on this unique set of measures in a large, nationally representative sample, this proposal seeks to understand how characteristics in the built environment may increase the risk of, or buffer against, mobility disability and participation restriction in older adults. The relationship between the built environment and mobility disability is complex, incorporating interactions between individual and environmental factors. A better understanding of the dynamics in this relationship is critical for the planning and development of 'age-friendly' environments, which allow older adults to 'age in place'.

Public health relevance
PUBLIC HEALTH RELEVANCE: Older adults are particularly dependent on their local communities, especially when they are no longer able to drive. Drawing on a unique set of measures in a large, nationally representative sample, this proposal seeks to understand how characteristics in the built environment may increase the risk of, or buffer against, mobility disability and participation restriction in older adults. A better understanding of the dynamics in the relationship between individual capacity and environmental demand is critical for the planning and development of 'age- friendly' environments, which allow older adults to 'age in place'. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Mobility, defined as an individual's ability to move about effectively in his or her surroundings, is fundamental to independence and quality of life. Difficulty with mobility (mobility disability) is highly prevalent in older adult populations, with negative consequences for independence in daily activities and social participation. Recent models of disability draw attention to the role of environmental factors that can interact with an individual's underlying impairments or capacities to impede or enhance a person's ability to be independent in mobility. For example, living on a street without continuous, barrier-free sidewalks may hinder mobility for a person living with leg weakness due to a stroke, with negative consequences for his/her ability to visit with friends down the street. Yet it remains unclear exactly which environmental factors are important for mobility, and for whom. Despite theoretical advances in our conceptualization of disability, the "environment" remains a largely unspecified term in disablement models. This research will use a unique nationally-representative data source to generate new knowledge at the intersection of individual capacity and environmental demand. The proposed research will conduct secondary analyses with data from the recently launched National Health and Aging Trends Study (NHATS). Funded by the NIA, NHATS is a nationally representative study of older adults, which seeks to push the envelope in this area of research by using a new disability measurement protocol designed to fill gaps in the measurement of key concepts along the disablement process. We will use data on the surrounding residential environment (gathered through interviewer observations of environmental factors in and around each respondent's home), coupled with objectively measured performance-based tests of physical capacity, to specify the role of environmental factors on mobility in older adults with different levels of physical capacity. We will examine the role of these environmental factors across older adults living in urban, suburban, and rural settings, and across different types of residential settings (single family homes, apartment buildings, assisted living facilities). We will also examine differences in effects across older adults using different mobility devices (cane, walker, wheelchair, scooter). We will use detailed measures of environmental features objectively collected in NHATS (including sidewalk quality, quality of walkways leading up to the home, ramps or steps at the entrance to the home), and also supplement this data for a subsample of respondents by collecting data on the broader neighborhood environment using a "virtual" neighborhood audit conducted with Google Street View. The proposed research will use innovative data and techniques to characterize in detail various features of the environment, and identify which environmental characteristics are important for mobility, in which context, and for which particular subpopulations of older adults. The findings will give us insight into why some older Americans report difficulty with outdoor mobility and why others do not. Simply using a generic concept of "environmental factors" when talking about the disablement process fails to aid our understanding in this process. Clarifying the "what", "where", and "for whom", behind this generic label will actually change the way we think about mobility disability, making it a more nuanced, specific, and dynamic construct. Ultimately, greater clarity in this construct will help to guide the development of interventions and policy initiatives designed to promote mobility in later life. Aim 1: To identify the environmental barriers and facilitators that are most salient for outdoor mobility disability in older adults. Using a unique, nationally representative data source of older adult functioning, we will examine the relationship between mobility disability and a broad array of environmental features (e.g. presence of sidewalks, quality of walkways, housing type), and identify the features that are most strongly related to independent mobility in older Americans (controlling for health and sociodemographic covariates). Aim 2: To identify whether there are particular sub-groups of older adults for whom environmental barriers or facilitators matter more than others. We will examine the relationship between environmental factors and outdoor mobility across different subgroups of older adults, including those with different levels of performance-based physical capacity, those using different assistive technology, those living in rural, urban, and suburban areas, and across those living in different residential settings (private home, assisted living, retirement facility). In terms of physical capacity, we expect that environments matter most for people with some degree of physical impairment, but less so for people free of impairments or for those who are highly impaired (for whom environmental facilitators would make no difference for mobility). Similarly, barrier-free, continuous sidewalks are likely to be important for independent mobility for those using wheeled mobility aids (e.g. scooter), but less so for those who do not rely on assistive technology for mobility.